IGF::OT::IGF TASK ORDER 18 - TERMS AND CONDITIONS OF THE BASE CONTRACT APPLY. MATERIAL LINE ITEM - EFFECTIVE DATE 6/15/2015

To continue the NCI Lifetime Cancer Risk Calculator and NCI Fallout Dose/Risk Calculator, the contractor shall expand the code development, perform extensive beta testing and QA/QC, create and update documentation for the calculator, set the calculator for online use; and provide a set of test parameters or exposure data to test calculator and then carry out those tests (with resolution of any errors encountered).